High speed, high information content single-molecule techniques for studying protein interactions and organizations in cells

Project summary
My research is focused on developing imaging tools and data analysis in single-particle tracking (SPT) and
single molecule localization microscopy (SMLM). My long-term goal is to push their resolution limits to
facilitate the study of protein interactions and organizations in cells at high spatiotemporal resolution. In
the next five years, my lab will focus on two research directions: 1) developing high-resolution two-color
SPT to study dimer formation and dissociation; 2) unifying data analysis for SMLM to extract maximum
information and achieve expert-free analysis. SPT has been widely used in studying protein dynamics and
interactions both in vitro and in live cells. However, the commonly used camera-based SPT methods are
limited to low spatiotemporal resolution. Real-time SPT techniques, such as MINFLUX, offer significantly
higher spatiotemporal resolution but are limited in their applications to two-color tracking. We will develop
a two-color SPT microscope based on real-time SPT techniques and apply the developed system to study
the interactions of epidermal growth factor receptor (EGFR) in live cells. EGFR, which plays an important
role in regulating cell growth, motility and differentiation, is an attractive candidate for anticancer therapy.
SMLM, as one of the major super-resolution microscopy techniques, can achieve a spatial resolution down
to 2 nm and has been increasingly used in structural biology to bridge the gap between electron microscope
and confocal microscope. Current SMLM data analysis pipeline consists of extracting the point spread
function (PSF), localization using the obtained PSF model, drift correction and post-analysis such as
clustering and particle averaging. This multi-step approach often complicates the data analysis procedure,
as each step requires a certain level of expertise. Taking advantage of the large-data processing capability
of deep neural network (DNN), we will develop a data-analysis framework based on DNN to achieve
simultaneous localization and PSF extraction from SMLM data. This framework can be extended to any
SMLM system and has the potential to extract all information from the data. I believe that the development
of fast, high-resolution, two-color SPT techniques will significantly advance the study of protein
interactions in cells. At the same time, a unified data-analysis framework for SMLM will render SMLM
techniques more robust and accurate, thereby establishing them as a standard tool for structural biology.

Public health relevance
Narrative Cellular signaling, molecular transport, and exchange are pivotal to cell functions, influencing both health and disease. However, many mechanisms of those processes remain enigmatic, especially within their native environment, due to the limited resolution and speed of current techniques. This project will develop new imaging and data analysis techniques that will enable the study of protein interactions and organizations in cells at high spatiotemporal resolution.